Metabolomic profiling of adolescent endometriosis

ABSTRACT
Endometriosis is a debilitating disease affecting 200 million women worldwide, causing severe pain and
infertility. Although over 50% of adults with endometriosis report onset of pain during adolescence, most
women with endometriosis experience a delayed diagnosis on average of seven years due to the current
diagnostic standard of surgical visualization, resulting in prolonged pain and decreased quality of life. Thus,
there is a critical need to identify novel, non-invasive biomarkers for endometriosis, which is one of the NICHD
research goals related to endometriosis. Being able to diagnose endometriosis earlier in the life course, during
adolescence and young adulthood, may lead to earlier intervention and improved clinical outcome. However,
little is known about the pathophysiology and molecular features of endometriosis diagnosed in adolescents.
Adolescent endometriosis typically presents with severe pelvic pain and superficial peritoneal lesions, which is
distinct from adult-diagnosed endometriosis which typically present with pain, infertility, and deep fibrotic
lesions. Furthermore, our preliminary data shows that about 30% of adolescents with endometriosis suffer from
persistent or recurring post-surgical pelvic pain despite being treated with post-surgical hormone therapy,
leading to recurring surgeries. Recently, we reported that blood CA125, which is elevated in endometriosis
diagnosed in adults, was not elevated in adolescents with endometriosis. Adolescent-diagnosed endometriosis
may have distinct molecular phenotype compared to adult-diagnosed endometriosis, which may require
different strategies for diagnosis and treatment. The objective of this application is to identify novel (1) blood
metabolomic profiles associated with adolescent endometriosis and (2) peritoneal fluid metabolomic markers
predictive of persistent post-surgical pain. Metabolites are the downstream products of cellular activities
regulated by the genome and modified by environmental factors and have proven valuable in biomarker
discovery for many chronic diseases. Based on our preliminary data, upregulation of prostaglandin synthesis
could be an important pathway for adolescent endometriosis pathophysiology given its common presentation
with pain. Using the detailed clinical information, pain measures, plus paired blood and peritoneal fluid samples
from the well-annotated longitudinal cohort of the Women’s Health Study: From Adolescence to Adulthood
cohort, we will apply a validated metabolomics platform which can simultaneously measure over 600
metabolites, allowing us identify metabolites and biologic pathways unique to adolescent endometriosis. The
proposed aims will identify novel metabolomic biomarkers of adolescent endometriosis which may lead to
advances in determining early diagnostic biomarkers and personalized treatment strategies for endometriosis.
Importantly, elucidating molecular profiles of adolescent endometriosis will provide new information about the
pathophysiology during the earlier course the disease trajectory, informing future R01 proposals to elucidate
changes in metabolomic profiles as the disease progresses from adolescence to adulthood.

Public health relevance
NARRATIVE Adolescent-diagnosed endometriosis may have distinct molecular phenotype compared to adult-diagnosed endometriosis, which may require different strategies for diagnosis and treatment. The proposed exploratory aims will identify novel blood metabolomic profiles associated with adolescent endometriosis and peritoneal fluid metabolomic markers predictive of persistent post-surgical pain. Results from this study will elucidate novel molecular profiles of adolescent endometriosis which will provide new information about the pathophysiology during the earlier course the disease trajectory, ultimately leading to novel early diagnostic strategies and tailoring personalized treatment which will have significant positive clinical impact on many young women and girls suffering from this debilitating disease.